Pilot Feasibility

PROJECT SUMMARY – PILOT/FEASIBILITY CORE
The Pilot/Feasibility Core will fund studies that will lead to improvements in the knowledge of underlying
mechanisms, diagnosis, or management of iTTP, cTTP and CM-TMA, and may generate data for future grant
applications. The core will fund the development of assessment of biomarkers, pilot studies of therapies or
interventions, novel laboratory assays, or analyses of clinical data collected in the longitudinal natural history
studies (Projects 1 and 2).